Replication studies for Kaposi Sarcoma mice

PROJECT SUMMARY/ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-RM-
24-013. Angiogenesis is central to cancer development; together with Angiosarcoma and Hemangioma, Kaposi
Sarcoma (KS) is the most angiogenic cancer in humans. KS is the most common cancer in people living with
HIV worldwide. In the USA today, KS is concentrated in underrepresented minorities (URM) of black race or
Hispanic ethnicity as well as in underserved and marginalized populations. The current frontline regimen for KS
was developed in the 1980s. Despite its discovery over 25 years ago, no proper, immune-competent animal
model existed for KS or aggressive angiosarcoma until last year, when we published a novel genetically
engineered mouse model (GEMM) funded by RO1 CA250080. This novel GEMM fills a gap that has hampered
novel therapy and vaccine developments for these cancers. The last experiment in our manuscript describes the
first drug evaluation in this new cancer model. We propose repeating this experiment with an independent CRO
to establish a repeatable, robust, and rigorous basis for the field. This will yield a best practices manual for drug
testing in this model.

Public health relevance
NARRATIVE New blood vessel development or angiogenesis is central to all cancers. Kaposi Sarcoma (KS) is the most angiogenic cancer in humans; it is the most common cancer in people living with HIV. We developed a new mouse model for aggressive KS, which fills a gap that has hampered novel therapy and vaccine developments for these cancers. We propose repeating our drug evaluation in this new cancer model with an independent CRO to establish a repeatable, robust, and rigorous basis for the field.